Mitochondrial mechanisms of maternal age effects on offspring health and lifespan

PROJECT SUMMARY
Advanced maternal age at the time of reproduction decreases offspring lifespan and health in a
range of species, including humans. The mechanisms controlling maternal age effects on
offspring are unknown, however. In our parent R01 project, we hypothesize that mitochondrial
dysfunction in advanced maternal age causes accumulation of dysfunctional mitochondria in
offspring through compensatory biogenesis and decreased autophagy during development. This
disrupts offspring mitochondrial function and mitochondrial-nuclear communication, leading to
accelerated offspring aging. The objectives of the parent project are to understand the
mitochondrial mechanisms by which maternal age determines offspring aging. In the parent
R01, we proposed to identify the maternal mitochondrial mechanisms that trigger maternal age
effects; identify the developmental mechanisms causing accumulation of mtDNA and damaged
mitochondria in old-mother offspring; and identify the offspring mitochondrial mechanisms
involved in negative maternal age effects and determine if these mechanisms are ROS-
dependent. When the parent project proposal was submitted, a method for CRISPR gene
editing in Brachionus rotifers was still in development. We have now successfully created a
protocol for high-efficiency CRISPR-mediated mutagenesis in Brachionus manjavacas. As
proof-of-principle for this new method, we created knockout mutations of VASA and MLH3, and
a knock-in mutation of a stop cassette in MLH3. Mutations were inherited over many
generations, demonstrating our ability to establish stable mutant lines. The availability of
heritable CRISPR induced mutation in Brachionus rotifers now makes it possible to test
mitochondrial mechanisms of maternal age effects more directly. The goal of this small-scale,
short-term Administrative Supplement project is to establish 5-7 stable knockout mutants and
knock-in fluorescent reporter strains for mitochondria-related genes in Brachionus manjavacas.
Establishing mutants for genes related to mitochondrial function and dynamics will allow us to
test the role of specific mitochondrial dynamics and metabolic pathways in maternal age effects
on lifespan and healthspan in the parent R01 and future studies.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH This project will contribute to our understanding of the molecular mechanisms that cause accelerated aging, decreased health, and shorter lifespan in offspring from older mothers. In this project, we will establish mutant strains for genes related to mitochondrial function and dynamics, hypothesized to be involved in negative effects of advanced maternal age on offspring lifespan and healthspan; this will allow us to test the role of specific mitochondrial dynamics and metabolic pathways in maternal age effects. Our work has the potential to identify a cause of interindividual variability in lifespan and to identify targets for therapies to improve health and increase lifespan.